Transgenic Mouse Core

Core 3. Transgenic Mouse Core
Abstract
Genetically engineered mice have been essential tools to study the function of immune genes in
mammals. To support the overall goals of the “Immunization against Multidrug-resistant
Pathogens: Activating T Cell Immunity” Center of Excellence for Translational Research
(IMPACT-CETR) and to control for the gut microbiota that could influence results, we have
centralized breeding of mice in the Transgenic Mouse Core. The Transgenic Mouse will supply
genetically engineered mice for the research projects. The overall coordination of breeding
animals will be through this core. Specific Aims are: 1) To monitor and maintain genetically
engineered lines for the projects. 2) To coordinate breeding and shipment demands with the
project leaders. 3) To provide assay support for genotyping as well as tissue specific
recombination for conditional knockout lines.